PHASE I STUDY OF TOPOTECAN IN COMBINATION WITH CYCLOPHOSPHAMIDE IN CANCER

This study treated 26 patients and defined the maximum dose of topotecan which could be safely given with cyclophosphamide. This drug combination will now be tested in a multi-institutional trial.